Characterizing metabolic variability during pregnancy to understand pathways of in-utero overnutrition: an integrative analysis of metabolomics and lifestyle data

PROJECT SUMMARY/ABSTRACT
Maternal-fetal resource allocation is governed by complex maternal physiological adaptations; however,
conditions such as obesity and Gestational Diabetes Mellitus (GDM) are associated with a suboptimal adaptive
response to pregnancy resulting in under- or overnutrition in utero. In utero overnutrition (i.e., fetal over-
nourishment by excess exposure to maternal fuels) is a concern given the earlier onset of obesity and
cardiometabolic disease in youth. Moreover, higher glycemia and adiposity, even below thresholds of clinical
GDM and obesity, have detrimental effects on offspring health. Such metabolic heterogeneity is noteworthy as
it influences target tissues involved in fetal development, such as the placenta. Characterizing metabolic
variability in pregnant women and assessing associations with offspring metabolic health will reveal nuances in
maternal phenotypes that contribute to metabolic disease risk in offspring. However, the associations of maternal
metabolic heterogeneity with maternal fuels (e.g., glucose, insulin, lipids) and modifiable behaviors are unclear.
Moreover, it is unknown if placental signaling, which is implicated in fetal programming, reflects metabolic
heterogeneity assessed via circulating biomarkers during pregnancy. Dr. Ellen Francis’ proposal addresses
these knowledge gaps by integrating low- and high-dimensional observational data and applying advanced
statistical techniques to test the hypothesis that distinct maternal metabolic subgroups correspond to differences
in placental signaling pathways, and that the maternal subgroups and placental pathways are involved in
programming of offspring metabolic risk. This proposal will use existing samples of fasting maternal blood during
pregnancy (N=1410), placental villus tissue, and collect new metabolomics in offspring at 4-8 years of age.
Through didactic instruction and mentored training, Dr. Francis will obtain training in the analysis of ‘omics data
within a lifecourse epidemiological framework to characterize metabolic variability in pregnancy and generate
metabolic subgroups related to adiposity and maternal fuels. She will advance her understanding of placental
and developmental biology (fetal programing) by receiving extensive hands-on-training (inclusion in lab and
bench training, and conference and seminar attendance) from mentors with expertise in placental and perinatal
biology. In the independent phase, she will use training gained in the mentored phase to assess if maternal
metabolic subgroups are reflected in placental nutrient sensing pathways, generate metabolomics data in
offspring and create offspring metabolic profiles. She will then assess whether maternal metabolic subgroups
are associated with offspring metabolic profiles in childhood, and the extent to which these associations are
mediated by placental nutrient sensing pathways. Findings from these complementary studies will improve our
understanding of metabolic pathways involved in fetal development, contribute to knowledge of how maternal
metabolic variability influences metabolic risk in offspring, and could reveal key cellular and behavioral targets
for prevention strategies, while assisting Dr. Francis’ to establish a career as an independent investigator.

Public health relevance
PROJECT NARRATIVE This proposal leverages a very well characterized and deeply phenotyped cohort of mother-offspring pairs to investigate different biological pathways by which the in utero environment may confer risk of obesity-related conditions in offspring during childhood. It will explore the relevance of metabolic subtypes during pregnancy, as a means to identify nuances in metabolism that are related to maternal fuels implicated in fetal programming (e.g., glucose, insulin, lipids) lifestyle intervention targets (e.g., diet, physical activity), placental signaling, and offspring’s metabolic profile. Findings from this study will improve knowledge of in utero risk stratification, maternal and child metabolic pathways involved in early life cardiometabolic risk and could reveal targets for prevention strategies to interrupt the transgenerational cycle of diabetes and obesity.